Reprogramming fibroblasts embryonic origins to overcome skin fibrosis and scarring.

7. Project Summary/Abstract
Adult human skin heals by developing fibrotic scar tissue, which can result in devastating disfigurement, growth
restriction, and permanent functional loss. Despite a plethora of clinical options, no current treatment strategies
successfully prevent or reverse this fibrotic process, and over $20 billion is spent each year in the United States
for the treatment of scars and their sequelae. Fibroblasts are recognized as the primary cell responsible for
depositing extracellular matrix and causing skin fibrosis. However, progress towards the development of
treatments aimed at reducing scars is impeded by a limited understanding of specific fibroblast subpopulations
responsible for regenerative healing. We have observed that neural crest-derived facial skin wounds heal with
less fibrosis than mesoderm-derived scalp wounds, somite-derived dorsal wounds, and lateral plate mesoderm-
derived ventral wounds. Furthermore, through single cell RNA sequencing, we have identified that neural crest-
derived facial fibroblasts promote regeneration following skin injury through a Robo2-EID1-EP300 axis, and
bromodomain inhibition of EP300 guides fibroblasts to heal with reduced skin scarring. In this proposal, we
examine the potential of the Robo2-Eid1-EP300 axis and EP300 bromodomain inhibition to guide dorsal scarring
fibroblasts to heal with reduced fibrosis. We will employ both cell transplantation and CRISPR-Cas9 approaches,
using histology, immunohistochemistry, transcriptional analysis, and flow cytometry to evaluate the regenerative
capacity of Robo2+ fibroblasts within wounds. We will then determine the role of EP300 interacting inhibitor of
differentiation 1 (EID1) in regulating Robo2 fibroblast activity in skin wounds. We will employ cell transplantation
and CRISPR-Cas9 approaches to robustly determine whether activation of EID1 promotes regeneration of dorsal
wounds to heal like facial wounds. Finally, having established that the Robo2-EID1-EP300 axis is responsible
for regenerative healing, we will inhibit EP300 signaling using both small molecule and transgenic approaches
to guide facial-like regenerative healing in dorsal wounds. Our ultimate translational goal is to develop
therapeutics that target fibrogenic wound cell dynamics to promote regenerative healing. Collectively, the
proposed work will significantly enhance our understanding of the key molecular and cellular determinants of
cutaneous scarring, shedding light on the contributions of Robo2-EID1-EP300 activity in wound repair and
scarring, and inform the development of novel anti-scarring therapeutics.

Public health relevance
8. Project Narrative Scarring is the end result of injury in adult skin and results in an enormous financial and medical burden for our society, yet no molecular therapies exist that can prevent scarring or its sequelae. Facial wounds heal with reduced scars compared to back and abdominal scars; however, molecular drivers governing the outcome of skin wounds derived from different embryonic origins remains unknown. Therefore, we will explore the biomolecular and tissue mechanical drivers of facial skin healing in order to facilitate development of novel targets to minimize scarring and promote regenerative wound healing.